Cancer Research Career Enhancement & Related Activities

CANCER RESEARCH CAREER ENHANCEMENT: SUMMARY
Through experienced leadership and continuous strategic investment, the Hollings Cancer Center (HCC) has
spearheaded cancer-focused educational and professional development activities across the Medical
University of South Carolina (MUSC) for more than two decades. Inherent to its core mission, the HCC offers
an innovative portfolio of training activities and career enhancement programming to maximize cancer-focused
career success and the advancement of a diverse cancer research workforce. Buoyed by significant
accomplishments, HCC leadership expanded its cancer research career enhancement activities during the
current project period. These accomplishments include the following HCC-driven initiatives and awards: a new
NCI-funded postdoctoral T32 for “Integrative Training in Oncogenic Signaling;” a new “Continuing Umbrella of
Research Experiences,” CCSG Supplement; a new NCI-funded R25, “SC Cancer Health Equity Consortium,”
summer undergraduate education award; two new U54s, the NCI-funded “SC Cancer Disparities Research
Center,” and the NIMHD-funded “Transdisciplinary Collaborative Center in Precision Medicine and Minority
Men’s Health,” both of which include education and training cores; new designation as the NCI-funded Region
1 South leader for the “Geographical Management of Cancer Health Disparities Program;” and recent renewal
of an NCI-funded K12, “Paul Calabresi Career Development Award for Clinical Oncologists.” Training at the
HCC now spans the education spectrum, from high school to undergraduates, to pre- and post-doctoral
trainees, to K-level and early stage investigators, to continuing education for health professionals in the
community. Institutional investment bolstered the support of national and international scholars through HCC-
supported pre- and post-doctoral fellowship and clinical scholar programs emphasizing early career physician-
scientists. The entire spectrum of cancer research training is now cohesively integrated under an umbrella
peer-to-peer support platform with an annual cancer research symposium celebrating excellence across
training disciplines and stages. What distinguishes the HCC’s educational and training enterprise are its
significant record of accomplishment in providing SC’s only comprehensive, cancer-focused research
education and training opportunities, the intentional inclusion of cancer disparities education in almost all of its
programs, and strong partnerships among key minority-serving institutions in SC and the region. In the next
cycle, the Associate Director of Education and Training, Chanita Hughes-Halbert, PhD (CC), with guidance
from an internal Educational and Training Leadership Council and HCC program leaders, will employ a
rigorous, continuous improvement strategy to track and evaluate HCC’s career enhancement efforts, and
develop novel approaches to further integrate education pipeline components through new experience-based
peer mentoring and interdisciplinary opportunities for engagement across multiple levels of learners.